Mechanism of Chromatin Accessibility, 3D Chromosome Organization, and Their Functions in Gene Regulation

Project Summary
One of the major focus of the parental grant, R35 GM139654, is to study the mechanism and
function of pioneer factors (PFs). Pioneer factors (PFs) can invade nucleosome and increase
chromatin accessibility near their binding sites and therefore play critical roles in gene
regulation. Mis-regulation of PFs is highly linked to cancer and developmental disease. Despite
their essential functions, the mechanism of nucleosome invasion by PFs and their function in
gene regulation require further elucidation. Particularly relevant to this supplement application,
we want to have a quantitative understanding of how pioneer factors affect gene expression
level, noise, and dynamics in the presence of signaling. Towards this purpose, we plan to
perturb pioneer factors and measure the consequences in gene expression in single cells
through time-lapse fluorescence imaging. Here, we request funding to purchase a microscope
system that allows us to perform long-term live cell imaging. This equipment will fulfill a critical
need for my lab, as well as the Center of Gene Regulation at Penn State, which my lab is part
of.

Public health relevance
Project Narrative Pioneer factors play essential roles in gene regulation, and their mutation and mis- regulation are highly linked to various types of human diseases. By perturbing pioneer factors and measure gene expression activity using time-lapse fluorescence microscopy, this supplement will allow us to study the function of pioneer factor quantitatively.